Developing single nuclei tRNA-seq to profile tRNA diversity at the single cell level

Project Summary/Abstract
Transfer RNA (tRNA) biogenesis is essential for determining the pool of tRNAs that set the translational state of
cells, and defects in the tRNA biogenesis machinery are associated with several types of neurodegenerative
diseases. While bulk tRNA-sequencing assays of tissues and cell cultures have revealed that tRNA expression
and modification are regulated in tissue and disease-specific manners, technology to date has hindered our
ability to define tRNA processing, expression, or modification changes in neurodevelopment and
neurodegeneration at the level of single cells, limiting important insight and therapeutic development. In this
application, we propose to develop and apply a novel tRNA sequencing method to stem cell derived
neurons and cerebral organoids to reveal complex tRNA processing and modification patterns at the
single cell level for the first time. We will utilize preexisting laboratory models to establish and optimize our
technology (Aim 1) before profiling cerebral organoids with pathogenic variants in CLP1 and isogenic controls
(Aim 2). These findings will reveal the complexity of tRNA processing and modification at unprecedented cellular
level resolution. In addition to neurodevelopment and neurodegeneration, our research will have broad impacts
on the study of tRNAs across all tissues, as it will be applicable to any frozen or fresh tissue source. Outside of
neurobiology, it will also benefit other fields such as cancer biology and virology where tRNA modulation is known
to be important.

Public health relevance
Narrative Transfer (t)RNAs are a class of small regulatory RNAs required for protein synthesis. Aberrant tRNA processing, modification, and expression has been associated with rare and common genetically complex neurological diseases, however, tools to measure tRNAs at the single cell level are lacking. We propose to develop a novel single nuclei tRNA sequencing method to profile tRNAs in human stem cell based organoid development and disease to reveal new pathophysiological mechanisms.